Center for Appalachian Research in Environmental Sciences-Community Engagement Core (CEC)

PROJECT SUMMARY- Community Engagement Core (CEC)
The University of Kentucky Center for Appalachian Research in Environmental Sciences (UKCARES)
Community Engagement Core (CEC) will grow, maintain, and enhance strong, sustained,
multidirectional community-academic partnerships that 1) support meaningful community
engagement; 2) build environmental health literacy; 3) reduce environmental health risks; and 4)
decrease poor health outcomes in rural Appalachia. Aging water infrastructure has resulted in
community concerns about water quality as well as emerging environmental health threats. The
CEC will build on a strong foundation of successful community engagement and support
environmental health science (EHS) by connecting investigators with
community partners to promote projects consistent with the three science themes of the Center—
(a) Health Impacts of Waterborne Contaminants; (b) Health Impacts of Indoor & Outdoor Airborne
Contaminants; and (c) Emerging Environmental Health Threats. The CEC will use an iterative
multidirectional process that brings local knowledge into the Center, leverages UK-CARES’
investigator strengths and institutional support, reports back research findings with at-risk
communities, and encourages solution-focused communication among community and
organizational stakeholders. Specifically, the aims of the CEC are to: 1) foster and cultivate
multidirectional community-academic partnerships engaged in UK-CARES research that is
responsive to regional environmental health issues, needs and concerns; 2) translate and
disseminate EHS findings through science communication training to foster clinical decision
making; and 3) strengthen partnerships with community and healthcare stakeholders in UKCARES’
environmental health research across the translational spectrum. First, we will engage our
Stakeholder Advisory Board members to offer culturally appropriate insight that will inform and
assist Center investigators in their research. The CEC will use formal (e.g., focus groups) and
informal (e.g., listening sessions) means to engage in multi-directional dialogue with community
stakeholders to assess environmental health concerns. In turn, the CEC will serve as a bridge to
and from the community to facilitate community engagement in EHS that leverages the strengths
of UK-CARES and is responsive to community concerns. Second, will provide training in effective
science communication with healthcare providers, faculty, and community stakeholders. We will
build on our impactful science communication training curriculum to prepare scientists for
effective communication of research findings. Lastly, we will collaborate with the TRSC to create
tailored multi-modal report back approaches to reach healthcare providers to promote clinical
decision making related to how the environment affects health in the region.